Molecular Analyses of Folate and Antifolate Transport

DESCRIPTION (provided by applicant): Folate-based drugs have been employed for decades in the treatment of cancer and inflammatory disease. These drugs, commonly termed antifolates, have met with success in clinical treatments but are severely limited due to their cytotoxic effects on normal cells. A prime example is the classic antifolate methotrexate (MTX), which is still commonly used at low doses in treatment of cancer, psoriasis and arthritic disease. Higher doses of MTX lead to obvious side effects including loss of hair as MTX preferentially kills rapidly dividing cells, normal or otherwise, without discrimination. Ideally, specific antifolates that target diseased cells without affecting normal cells could be developed. In studying folate transport, researchers have discovered that human folate receptor proteins (hFRs) are overexpressed in many tumor types and also activated macrophages at the site of inflammatory conditions (e.g. arthritis). Furthermore, the expression of hFRs on normal tissue is localized such that is not exposed to drugs administered intravenously. Taken together, antifolates that are designed to be taken up specifically by hFRs could be administered intravenously with minimal toxicity to normal tissue. Our proposal seeks to advance the development of novel hFR-specific antifolate drugs through extensive structural, thermodynamic, kinetic and cell-based characterizations of the interaction of hFRs with folate and antifolate ligands. Specifically our aims are to: 1) Determine the X-ray crystallographic structures of human membrane folate receptor types 1 and 2, targets for tissue selective delivery of experimental antifolate and folate-conjugate drugs, to aid in the design of new drugs to treat cancer and inflammatory diseases; 2) Elucidate the biophysical parameters of ligand binding and release by human folate receptors to ultimately delineate the desired structural features for folate-based drugs; and 3) Analyze human folate receptor mutants to identify key determinants of FRs required for trafficking and release of folates and antifolates in situ. Given the long history of folate-based drugs in disease treatment, the obvious lack of molecular insight into hFR-ligand interaction is disappointing at best. Completion of these studies will lead to a set of molecular parameters that will guide the rational design of the next generation of antifolates, leading to profound improvements in public health relating to cancer and chronic inflammatory disease.

Public health relevance
PUBLIC HEALTH RELEVANCE: Our proposed research program has the potential to improve public health by substantially improving the treatment of many prevalent human cancers. During chemotherapy treatment for cancer, many adverse side effects are realized by the patient due to the toxicity of the chemotherapeutic drugs in normal cells. Our work should lead to the development of novel drugs that specifically target cancer cells and therefore improve patient therapy with the added benefit of fewer side effects. Project Narrative Our proposed research program has the potential to improve public health by substantially improving the treatment of many prevalent human cancers. During chemotherapy treatment for cancer, many adverse side effects are realized by the patient due to the toxicity of the chemotherapeutic drugs in normal cells. Our work should lead to the development of novel drugs that specifically target cancer cells and therefore improve patient therapy with the added benefit of fewer side effects. __SpecificAimsTextDelimiter__ I. SPECIFIC AIMS General significance and rationale The work proposed herein will have a substantial impact on the treatment of many prevalent human cancers and inflammatory diseases. The glycosyl-phosphatidylinositol (GPI)-anchored cell surface human folate receptor type α (hFRα) is a tumor marker over- expressed in several major malignancies of epithelial origin (1-4). Consequently, hFRα is widely recognized as a potential target for the selective delivery of a broad range of therapeutic agents to tumors(5-10). In addition, human folate receptor type β (hFRβ) is overexpressed in activated macrophages involved in inflammatory disease (11-14). The experimental drugs include folates conjugated to cytotoxic drugs, folate-coated nanoparticles and hFR-directed immunotherapies (15-20). More recently, in vitro and pre-clinical studies of a new generation of potent antifolate compounds has shown promise of a paradigm shift in the development of new antifolate therapy, since the compounds are entirely dependent upon hFR for cellular uptake (22, 23) (24, 25). Currently used antifolate drugs are limited by toxicity due to their uptake by non-target tissues through unrelated but ubiquitous folate transport systems including the reduced folate carrier (RFC) (26, 27). hFR-specific antifolates can overcome this limitation. In order to improve the design of hFR-specific antifolates, it is essential to elucidate the three-dimensional structures of hFRs in states that mimic folate uptake and trafficking for both folates and antifolates. Using these structural data in conjunction with the current knowledge of molecular pharmacology of antifolates, a basis for rational (i.e. not entirely empirical) design of novel, hFR-targeted antifolate drugs will be developed. With this approach, we expect to produce the next generation of antifolate drugs; such drugs will be expected to not only be far more effective than most current chemotherapies but will also be readily accepted in a clinical setting due to the long tradition of using antifolates in cancer chemotherapy. Aim 1: Determine the X-ray crystallographic structures of human membrane folate receptor types α and β, targets for tissue selective delivery of experimental antifolate and folate-conjugate drugs, to aid in the design of new drugs to treat cancer and inflammatory diseases. Researchers have been studying folate receptors for many decades, and yet no structural models exist to advance the field of folate-targeted drug delivery. Aim 1 specifically addresses this gap in knowledge. We will: 1A. Determine the structures of hFRα and hFRβ at a range of physiological pH values that mimic transport of folates in vivo. 1B. Determine complex structures of hFRα and hFRβ with available antifolates. 1C. Utilize the information gained from structures to rationally design new antifolates with a high probability of being hFR-specific. Aim 2: Elucidate the biophysical parameters of ligand binding and release by human folate receptors to ultimately delineate the desired structural features for folate-based drugs. hFRs bind folates and antifolates with subnanomolar affinities (Kd values). This commonly used statement largely represents the extent of our knowledge of the biophysical characterization of folate receptors. Aim 2 will rigorously evaluate the interactions of hFRs with folates and antifolates at multiples pH values and provide data based on equilibria, thermodynamic and kinetic experiments to define structure activity relationship (SAR) parameters for successful antifolate drug design. We will: 2A. Characterize binding equilibria of hFRα and hFRβ with folates and antifolates via a combination of intrinsic fluorescence and fluorescence anisotropy experiments. 2B. Determine the binding equilibria constants of folates with structure-based mutants of hFRα. 2C. Characterize the thermodynamic parameters of folate and antifolate binding to folates and antifolates using isothermal titration calorimetry. 2D. Examine the kinetics of folate binding to hFRα and hFRβ using surface plasmon resonance. Aim 3: Analyze human folate receptor mutants to identify key determinants of hFRs required for trafficking and release of folates and antifolates in situ. Using our structural model, we have made a number of mutations of hFRα. We wish to examine the effects of our mutations on transport of folates with the added ability to rationalize our finding based on our structural model. We will: 3A. Stably introduce hFRα structure-based mutants into non-FR expressing cells. 3B. Perform transport assays with H3-folic acid and competition assays with H3-folic acid and folates or antifolates using the cell lines generated in Aim 3A to determine the molecular determinants in hFRα responsible for proper transport of folates and antifolates.